Mechanism of Par3-mediated regulation of dendritic spine plasticity

Project Summary/Abstract
Dendritic spines are small, highly polarized protrusions on excitatory neurons serving as sites of postsynaptic
input. Plasticity of dendritic spines is necessary for learning, while stable dendritic spines are thought to encode
long-term memories. The polarized nature of dendritic spines suggests their plasticity and stability may be
mediated by polarity proteins. The Partitioning defective (Par) polarity protein 3 (Par3) regulates mature dendritic
spine formation in vitro, and several single nucleotide polymorphisms (SNPs) and copy number variation (CNV)
of Pard3, which encodes Par3, are associated with intelligence, schizophrenia, and autism spectrum disorder
(ASD). Moreover, Par3 forms a complex with atypical protein kinase C (aPKC). A constitutively active truncated
aPKC variant has been proposed as a “memory molecule,” while a full length aPKC variant is implicated in long
term potentiation (LTP). Together, these data implicate Par3 in mature dendritic spine stabilization, which may
play a role in cognition and social interactions. However, the in vivo mechanisms of Par3 in dendritic spine
plasticity and stability remains completely unknown. To investigate the mechanisms, we developed a novel
conditional knockout line that depletes Par3 in postnatal forebrain pyramidal neurons (Par3-/-). Par3-/- exhibits
increased dendritic spine density and increased immature dendritic spine morphology. Phosphoproteomic
analysis of Par3-/- hippocampal tissue revealed increased phosphorylation of CAMSAPs, which bind and stabilize
microtubule (MT) minus-ends. Our central hypothesis is that Par3 regulates MT stability through CAMSAPs to
stabilize dendritic spines, which is necessary for normal cognition and social interactions. In the absence of Par3,
aPKC becomes abnormally activated leading to increased CAMSAP phosphorylation and decreased MT
stability. Aim 1 investigates the hypothesis that loss of Par3 destabilizes dendritic spines leading to impaired
cognitive functions and social behavior in mice. Aim 2 uses biochemical assays and live cell imaging to test the
hypothesis that Par3 regulates aPKC phosphorylation of CAMSAP2 at S992, influencing MT and dendritic spine
stability.
Together, these experiments will elucidate the in vivo mechanisms of Par3 regulation of dendritic spine
stability, cognition, and social behavior. This may provide important insight to further understand the mechanisms
of neurodevelopmental disorders, such as schizophrenia and ASD. The proposed fellowship will also train the
applicant in several innovative techniques in biochemical, cellular, molecular, and behavioral neuroscience. The
established faculty-student mentorships will ensure proper scientific and professional training necessary to
become a successful, independent neurobiologist of learning and memory.

Public health relevance
Project Narrative Neurodevelopmental disorders, such as schizophrenia and autism spectrum disorder (ASD), are characterized by dendritic spine morphology and density aberrations. This project aims to determine the mechanism of Par3- mediated regulation of dendritic spine stability. Since several Par3 mutations are associated with schizophrenia, ASD, and intelligence, this study may reveal how Par3 contributes to both dendritic spine stability and neurodevelopmental disorders.